A novel Lyme disease vaccine

PROJECT SUMMARY
A novel vaccine for Lyme disease
Acquired resistance to Ixodes scapularis, commonly known as “tick resistance”,
can prevent transmission of Borrelia burgdorferi, the Lyme disease agent. We have
shown that tick resistance can be generated in guinea pigs (1) repeatedly exposed to I.
scapularis, (2) immunized with I. scapularis saliva, or (3) immunized with a lipid
nanoparticle containing mRNAs encoding 19 saliva proteins (19ISP). In addition,
salivary protein 14 (Salp14), a component of 19ISP, elicits partial tick resistance.
The goal of this proposal is to identify the specific proteins in I. scapularis
saliva that elicit tick resistance and demonstrate that vaccination with these
proteins can prevent B. burgdorferi infection. We will delineate the importance of
Salp14 and additional saliva proteins in tick resistance, determine the host responses
that are associated with tick resistance, and examine whether vaccination with saliva
proteins or mRNAs encoding each saliva protein can prevent B. burgdorferi infection.
These studies will lead to new knowledge to aid in the development of a novel vaccine
which may prevent Lyme disease and, possibly, other tick-borne infections.

Public health relevance
NARRATIVE Acquired resistance to ticks is commonly known as “tick resistance”. This proposal seeks to elucidate the antigens in Ixodes scapularis saliva that contribute to the development of tick resistance and characterize the host response to these antigens. This will lead to important new information that can be used to develop a novel vaccine to prevent Lyme disease and, potentially other tick-borne infections.